Mechanobiology of fracture healing during skeletal disuse

PROJECT SUMMARY/ABSTRACT
Decreased muscle and bone mass and strength resulting from musculoskeletal unloading (disuse
osteosarcopenia) has long been associated with increased fracture risk, impaired bone healing and worse
patient outcomes. Current disease modifying drugs are centered primarily on bone targeted therapies (anti-
resorptives and PTH), and remain ineffective at targeting muscle loss that appears crucial for healthy bone
repair and reducing fall risk. Although early reambulation and physical rehabilitation following bone injury is
known to be beneficial for fracture healing and muscle recovery, there remains a gap in our knowledge of the
appropriate mechanical loading regimens following osteosarcopenic fracture due to limited knowledge of how
disuse affects fracture healing mechanobiology. In preliminary work, we have a developed a murine model of
fracture healing during disuse by hindlimb unloading, with and without remobilization. This model recapitulates
many clinical features of bone repair during disuse (decreased skeletal muscle mass, decreased
radiographical callus formation) with new findings such as altered callus vascularity and osteoclastogenesis
that are attenuated with reambulation. The aims outlined in this proposal seek to greatly expand upon our
preliminary studies by using non-invasive loading modalities targeting muscle and or bone directly to determine
the critical cellular and molecular mediators of callus mechanobiology during disuse. In the mentored K99
portion of this grant, we will utilize non-invasive optogenetics and direct tibial loading to determine optimal
mechanical inputs to increase callus healing, biomechanical integrity, and muscle mass during disuse (Aim 1).
Next using high-throughput techniques (RNAseq and flow cytometry), we will investigate the potential
underlying mechanisms by which non-invasive loading affects callus mechanobiology during disuse (Aim 2).
During the R00 phase, Dr. Buettmann will leverage recent mechanistic findings to determine the conditional
role of mechanosensitive molecules in coordinating load-induced alterations in fracture healing during disuse
(Aim 3). These insights will help bridge a significant gap in our understanding of how disuse alters callus
mechanobiology and how mechanically-regulated molecules can be leveraged to improve fracture healing and
rehabilitation in osteosarcopenic “high risk” patients. These findings, owing to the preclinical model’s
translatability, could also have far-reaching implications for other pathologies associated with impaired fracture
healing and altered mechanosensation such as aging, obesity/diabetes, and hormonal deprivation. Dr.
Buettmann has assembled a mentoring team and collaborators with expertise in bone
regeneration/osteoimmunology (Drs. Olivares-Navarrete), optogenetics and muscle-bone mechanoregulation
(Dr. Megan Killian), musculoskeletal bioinformatics (Dr. Charles Farber), biomechanics (Dr. Hannah Dailey)
and mechanobiology (Dr. Henry Donahue). This project will prepare Dr. Buettmann for an independent
research career in musculoskeletal research by acquiring the necessary training and research data for an R01
equivalent award.

Public health relevance
PROJECT NARRATIVE Extended periods of musculoskeletal disuse and unloading, such as found during paralysis, bedrest, and or spaceflight, increase the risk of bone and muscle weakness and fragility fracture. Treatment options for patients with fractures during musculoskeletal disuse are limited because very little is known about how mechanical loads (or lack thereof) are sensed by different bone cell populations to regulate healing. This project seeks to use a controllable muscle and bone loading platform to identify what mechanical interventions and molecular mechanisms are necessary to improve fracture healing and muscle strength during extended disuse.